Targeting CCL20-CCR6 Interactions in Colorectal Cancer

Background and Innovation: Novel treatment strategies for colorectal cancer are desperately needed.
Despite significant advances in the treatment of metastatic disease, patients healthy enough to receive
intensive therapy still only survive 2-3 years. Chemokines have emerged as a crucial link between tumor-
promoting inflammation and cancer. CCR6 is the only known receptor for the inflammatory chemokine CCL20,
which in turn is the only known chemokine ligand for CCR6. Several lines of evidence suggest that interactions
between the inflammatory chemokine CCL20 and its receptor CCR6 play a key role in the development and
progression of colorectal cancer. To date, however, beyond our preliminary results, there is a paucity of in vivo
data on the effect of disrupting CCL20-CCR6 interactions in colorectal cancer in the setting of an intact
immune system or in testing how targeting CCL20-CCR6 interactions can be rationally integrated into the
treatment of colorectal cancer. We have found that CCL20-CCR6 interactions promote intestinal
carcinogenesis and colorectal cancer growth in animal models. We have observed that CCL20-CCR6
interactions induce tumor-promoting effects, such as proliferation, migration, EMT and further secretion of
CCL20, on neoplastic epithelial cells. Blockade of CCL20 abrogates colorectal cancer neoplastic epithelial cell
migration, proliferation and EMT mediated by inflammatory tumor conditions. We have shown that autocrine
HGF-c-MET and MSP-MSPR signaling pathways mediate tumor-promoting effects on neoplastic epithelial cells
induced by CCL20-CCR6 interactions. In addition to the effects on neoplastic epithelial cells, we have found
that CCL20-CCR6 interactions in tumor stroma promote colorectal cancer as transplanted colon cancer cells
expressing CCR6 had delayed growth in CCR6-deficient host mice. We identified macrophages as an
important mediator of this stromal tumor-promoting effect. Macrophage infiltration is decreased in the setting of
CCR6 deficiency in mice, and CCL20 induces monocyte/macrophage migration in vitro and in vivo.
Transplanted colon cancer growth is delayed by depletion of tumor macrophages. Furthermore, we have found
that tumor macrophages secrete inflammatory mediators that induce proliferation of colon cancer cells.
Recently, we have begun to investigate targeting CCL20-CCR6 interactions in combination with the use of
approved therapeutic agents for colorectal cancer. Notably, we have found that 5-FU induces secretion of
CCL20, and that blockade of CCL20-CCR20 interactions improves the efficacy of 5-FU and cetuximab cell
killing. Thus, we hypothesize that targeting the CCL20-CCR6 axis can improve the treatment of colorectal
cancer. To test this hypothesis, and to further elucidate the role of the CCL20-CCR6 axis in colorectal cancer,
we aim to: 1) identify novel targets for colorectal cancer in the CCL20-CCR6 axis; 2) characterize the changes
in the immune microenvironment of colorectal cancer induced by targeting CCL20-CCR6 interactions; and 3)
evaluate the role of targeting CCL20-CCR6 interactions in sensitizing colorectal cancer to treatment with
approved systemic agents. This project has several innovative aspects including: targeting a pathway with the
potential to affect both neoplastic cells and tumor stroma; exploration of a target with promise of enhancing
existing treatments; the use of cutting-edge models and methods; and evaluation of a novel therapeutic.
Significance and Impact to Veterans Healthcare: This project has the potential to improve the treatment and
outcome for colorectal cancer patients. Colorectal cancer screening and optimal treatment delivery are major
targets for quality improvement in VHA. Colorectal cancer affects 4,000 patients each year in VHA.
Path to translation/implementation: The proposed studies will shed light on the role of the CCL20-CCR6
axis in colorectal cancer. We believe that these studies will determine the clinical relevance and therapeutic
importance of interactions between CCR6 and CCL20 in this disease and should pave the way to integrate
targeting of this pathway in the treatment of colorectal cancer for human patients.

Public health relevance
Colorectal cancer remains a major cause of disease and death in veterans. Despite modern treatment, the outcome for patient with metastatic disease remains poor. Chemokines are vital signaling molecules in the tumor microenvironment. Our preliminary data and other supporting studies suggest a crucial role for the chemokine CCL20 and its receptor CCR6 in promoting colorectal cancer through actions on both neoplastic epithelial cells and stromal cells. Targeting the CCL20-CCR6 axis for the treatment of colorectal cancer appears promising, however, this concept has not been well studied. We hypothesize that targeting interactions between CCL20 and CCR6 can improve the treatment of colorectal cancer. This project will evaluate this hypothesis using novel approaches and will investigate innovative strategies for the integration of targeting CCL20-CCR6 interactions in the treatment of colorectal cancer. We hope that this project will lead to initiation of clinical trials and to the ultimate adoption of targeting the CCL20-CCR6 axis in clinical practice.